Advancing Causal Inference in Integrative Omics Analysis

Project Summary
Emerging and rapidly progressing technologies can now measure the molecular phenotypes of genes,
transcripts, proteins, metabolites, and gut microbiota. These omics data provide an unprecedented level
of granularity into both clinical and biological measurements, showing great promise to understand
biological mechanisms governing human health and disease, and to uncover the underlying hetero-
geneities that contribute to disease manifestations. However, many statistical methods used for analysis
of omics data only establish associations. These associations may merely represent correlates or con-
sequences of disease processes, and thus may not reveal disease mechanisms or guide therapeutics
and clinical care. On the other hand, existing causal inference methods are not adequately equipped
to handle the high dimensionality, correlation, and complexity of omics data. The goal of this project
is to develop new statistical methods for causal inference that integrate large-scale omics data and im-
plement them in user-friendly open-source software. We will develop a new framework that broadens
the scope of mediation analysis to jointly analyze high-dimensional omics mediators, through novel ap-
plications of two powerful ideas in statistics and machine learning: sufﬁcient dimension reduction and
variational autoencoders. The proposed framework can identify a disentangled representation of key
mediation pathways, effectively distilling vital signals from large-scale omics mediators. Moreover, we
will develop robust and scalable multivariable Mendelian randomization methods for large-scale omics
measures, and then extend these methods to identify shared risk pathways across multiple outcomes.
Lastly, we will introduce a novel framework for testing the pairwise causal directions between two omics
modalities (e.g., microbiome and metabolites) by leveraging the asymmetry in temporally-ordered data.
To maximize the impact of the proposed methods, we will develop and maintain open-source software
for our methods, and integrate our proposed Mendelian randomization methods into two state-of-the-art
platforms (MR-Base and MendelianRandomization). This project aims to address the need for robust,
rigorous, and computationally efﬁcient causal inference in large-scale omics data, and ultimately trans-
form the potential of massive biomedical data into trustworthy, actionable, and generalizable knowledge
to solve public health challenges.

Public health relevance
Project narrative Advances in omics technologies – such as genomics, transcriptomics, proteomics, and metabolomics, and microbiomes – have introduced an unprecedented level of granularity into both clinical and bio- logical measurements. However, using these data to discern causal factors and mechanisms under- lying diseases is challenging due to their high dimensionality, correlation, and complexity. The current proposal aims to address this gap by developing rigorous causal inference methods and software for integrative analysis of omics data, providing new insights on disease etiology and ultimately transform the potential of massive biomedical data into trustworthy, actionable, and generalizable knowledge to solve public health challenges.